Bloomington Drosophila Stock Center at Indiana University

Project Summary The Bloomington Drosophila Stock Center (BDSC) collects, curates, maintains and distributes strains of the fly Drosophila melanogaster to support the biomedical research community. It is the largest and most comprehensive Drosophila stock collection in the world, and it is central to the success of many research projects. The BDSC depends heavily on the smooth, efficient and dependable functioning of a media kitchen and dishwashing facility to produce and clean over four million vials of culture media used every year in the maintenance of live cultures. This proposal requests supplemental funding to replace aged pieces of equipment that represent weaknesses in reliability. Specifically, the kitchen cooker system needs a new temperature control unit installed to provide heat to the jacket of the kettle used to cook fly food and a new tank heater to preheat water as a food ingredient. The dishwashing facility needs a new autoclave for melting the agar-based food prior to clean up.

Public health relevance
Project narrative The Bloomington Drosophila Stock Center is the U.S. repository and distribution center for genetically characterized strains of Drosophila melanogaster, a model organism used in thousands of laboratories worldwide both to investigate fundamental biological processes and to understand cellular mechanisms related to human diseases. The proposed work will replace critical pieces of equipment in the media preparation and glassware cleanup facilities that have reached or exceeded their expected lifespans to promote the continued smooth operation of the Center.